Implementing a Maternal health and PRegnancy Outcomes Vision for Everyone (IMPROVE)

In Georgia, black women account for 60% of pregnancy-related deaths and are 3.3 times more likely to die than non-Hispanic Whites. The Georgia Clinical and Translational Science Alliance (Georgia CTSA) through this administrative supplement, will establish a foundation for the Implementing a Maternal health and PRegnancy Outcomes Vision for Everyone (IMPROVE), across the state of Georgia. Georgia-IMPROVE will establish a community focused multidisciplinary perinatal care research and intervention network (PCRIN) to inform priorities on preventable maternal mortality (MM), severe maternal morbidity (SMM), and to promote health equity. The overall goals of Georgia IMPROVE are to 1) incorporate strategic community partnerships and participation to address health disparities in maternal health; and 2) establish a foundation to expand research on the leading causes of MM and pregnancy related morbidity, with a focus on patient centered evidence-based prevention. This project aligns with and is in the scope of Georgia CTSA Community engagement, Integrating special populations and Informatics programs, and will establish a foundation for a Perinatal Care Research and Intervention Network (PCRIN) that will inform future research, with data on sociocultural and behavioral determinants of MM/SMM. The specific aims are to: 1) Develop a multi stakeholder, community-based Perinatal Care Research and Intervention Network (PCRIN) of women, healthcare providers and health systems, to identify barriers to, and develop stakeholder-informed solutions for optimal maternal health equity. 2) Conduct a Pilot feasibility study of patient-centered perinatal care coordination, using remote monitoring, to support care transition from perinatal through 42 days postpartum. These findings will support future research that will prioritize the needs of women and their families, as well as inform culturally congruent approaches in care transitions.

Public health relevance
Project Narrative Georgia IMPROVE will inform an integrated approach to understanding the biological, behavioral, sociocultural, and structural factors contributing to Georgia’s high maternal mortality and severe maternal morbidity which disproportionately impacts black women.